Development of a minimally invasive optical biosensor to improve hyperphosphatemia management

PROJECT SUMMARY
Calcium and phosphate homeostasis is significantly disrupted in advanced chronic kidney disease
(CKD) and end-stage kidney disease. Elevated serum phosphate concentration – a condition known
as hyperphosphatemia – is a significant cause of cardiovascular morbidity and mortality in this
population. Thus, physicians treat these patients with dietary restriction of phosphorus intake and
medications that inhibit the absorption of ingested phosphorus. The standard of care is to titrate these
interventions to a patient’s serum phosphate concentration, but this level is checked only at monthly
intervals, which provides only an infrequent snapshot of a patient’s dynamic condition. Thus, new
technology for phosphate monitoring is needed to empower physicians and patients to better manage
hyperphosphatemia. The objective of this project is to address this need through the development of
an optical biosensor that can be used to non-invasively measure serum phosphate concentration.
Aim 1 is focused on biosensor development, which will be approached by designing hydrogel
composites encapsulating metalloporphyrin-containing biosensor particles that will transduce
phosphate concentration to an optical signal that can be detected through the skin. In vitro testing
under simulated physiologic conditions will be performed to optimize the range and sensitivity of the
biosensor. Aim 2 encompasses in vivo testing of the biosensor. Testing will be performed in the
Col4a3 knockout mouse model of CKD, which exhibits dysregulated calcium and phosphate
metabolism and hyperphosphatemia. Biosensor performance will be evaluated by comparison to
blood and interstitial fluid measurements of phosphate. If successful, this project will provide a
foundation for subsequent testing in a large animal model of CKD and efforts toward clinical
translation.

Public health relevance
PROJECT NARRATIVE Elevated phosphate levels cause significant mortality in patients suffering from chronic kidney disease. While this problem can be mitigated by reducing dietary phosphate and taking phosphate binders with meals, patients do not currently have a tool to monitor their phosphate level and manage their condition. The goal of this project is to address this need by developing a biosensor that can be used to non-invasively monitor phosphate concentration.